Role of the early life gut microbiome on immunoglobulin A and colonic immune development

ABSTRACT
The gut microbiome and immune system develop in concert, influenced by environment, diet, infections, and
antibiotics. Secretory immunoglobulin A (sIgA) in breastmilk is the primary mediator of coordinated immune and
microbiome development, modulating host-bacterial interactions. Breastmilk sIgA is the main source of IgA be-
fore the first month of life, and formula-fed infants lack sIgA exposure during this critical period. Antibiotics ad-
ministered during infancy lead to dramatic changes in microbiome composition during a critical period for regu-
lation of gut inflammation. Preterm infants are more likely to be exposed to antibiotics, are more susceptible to
bacterial infection, have less mature gut microbiomes, and have persistent alterations in immune development
relative to their term counterparts. Animal models are essential to precisely control the complexity and variables
of human immune and microbiome development. Gnotobiotic mouse models have been used to determine how
individual strains impact immune development in adults. However, <25% of species tested in these models have
>5% prevalence among infants. Therefore, new models are necessary to determine the impacts of microbes that
colonize human infants on the developing immune system. We have developed a gnotobiotic mouse model of
colonizing germ-free mating pairs with bacterial isolates or fecal samples from human infants. Pups are born
microbiome-humanized, avoiding the negative immune consequences of lack of microbial exposure. Just as in
human neonates, the gut microbiome of these mice matures over time, and we find that microbiome similarity
correlates with cellular and secreted markers of immune response. The rationale for our proposal is to use this
model to understand how human-associated microbes impact immune development, sIgA bacterial binding, and
susceptibility to antibiotic-mediated disruption and bacterial pathogen colonization. In Aim 1, we colonize gnoto-
biotic dams with the most abundant and prevalent bacterial isolates or combinations colonizing human infants
from two clinical cohorts of 80,000 fecal samples from over 1,050 hospitalized preterm or community term infants.
By using germ free breeding pairs homozygous or heterozygous IgA knockout mice, we will evaluate how ma-
ternal or infant sIgA impacts immune development. In Aim 2, we colonize wild-type germ-free mice with preterm
or term fecal samples and evaluate immune disruption relative to antibiotic treatment. In Aim 3, we evaluate
immune tolerance and susceptibility to E. coli challenge with rescue with IgA supplementation. Our proposal is
innovative because our interdisciplinary research team will complement data from unique human cohorts in a
gnotobiotic mouse model that recapitulates microbiome and immune development and disruption by antibiotics
and infectious challenge. This proposal is significant because we will use sophisticated multivariate analyses
to precisely determine how prevalent infant-associated microbes differentially affect immune development. Our
work is impactful because we will advance understanding of the co-development of the gut microbiome and
immune system and establish a predictive framework for promoting healthy microbiome-immune interactions.

Public health relevance
PROJECT NARRATIVE The proposed study addresses our gap in understanding how the early-life immune system develops with microbial and dietary inputs and antibiotic exposure. This research is relevant for public health because we are utilizing an innovative mouse model to define the roles of human infant microbes on gut immune development and disruption by antibiotics and infection. Our goal is to provide a framework to use gut microbiome composition to predict and abrogate negative immune consequences, such as childhood infection and inflammatory disease.